Redox manipulation of iron to improve glioblastoma therapy: A phase 1 trial

Project Summary & Abstract
Glioblastoma (GBM) is a deadly primary brain cancer with a median overall survival (OS) of only 14-16
months. Despite a treatment regimen including surgical resection followed by radio-chemo-therapy, the
majority of patients will recur within 7 months of diagnosis. We identified in a phase 1 trial that pharmacological
ascorbate (PAscH-; IV vitamin C reaching ≈ 20 mM in plasma) combined with standard GBM therapy is well
tolerated with promising outcomes in poor prognosis subjects with MGMT positive/IDH1 wild type tumors. This
led to the recent completion of enrollment of a PAscH- GBM phase 2 trial (NCT02344355) treated with
standard radiation and temozolamide and PAscH-. Median OS in the GBM phase 2 trial was 22 months.
Our research team made the exciting mechanistic observation that PAscH- selectively enhances GBM radio-
chemo-therapy, relative to normal human astrocytes, because of differences in the metabolism of redox active
iron (Fe). This mechanism results from the selective increased Fe-mediated oxidation of ascorbate in tumor
tissue leading to the formation of hydrogen peroxide (H2O2). H2O2 can be directly toxic to cancer cells or can
react with Fe through Fenton chemistry to produce hydroxyl radicals that damage DNA, proteins, and lipids
and hence synergizes with radio-chemo-therapy. Furthermore, preliminary analysis of the PAscH- GBM phase
2 trial identified that subjects with increased tumor Fe, detected by magnetic resonance imaging (MRI) T2*
relaxation, had significantly increased progression free survival (11.2 months vs. 5.7 months). This suggests
T2* relaxation may be a non-invasive biomarker to predict Fe dependent response to PAscH-.
Ferumoxotyol (FMX) is an Fe oxide nanoparticle used in glioma MR imaging. Preliminary pre-clinical data
show that ascorbate and ionizing radiation facilitate the release of Fe from FMX that can be detected by
alterations in MRI parameters (T1 enhancement and decreased T2* relaxation time). The released Fe would
then be available for the therapeutic enhancement of PAscH-. In GBM human tumors, FMX mediated T1
enhancement detects Fe release for up to 72 hours after infusion in the tumor and surrounding edema volume.
Given this exciting preliminary data, FMX may represent the ideal GBM imaging and therapy agent when
combined with PAscH-. We hypothesize iron supplementation with FMX in combination with PAscH- and
standard of care therapy will be safe and increase redox active Fe content (detected by T2* relaxation)
in GBM tumors as part of a phase 1 clinical trial. Each subject’s GBM tumor will be analyzed by T2* MRI for
changes in redox active Fe as well as assessing plasma for evidence of Fe overload and liver injury.
Completion of these studies will assess the impact of the redox active Fe manipulation on GBM therapy. If
successful, future phase 2 studies will investigate the potential of combining PAscH- and FMX with standard
GBM therapy to improve survival and sensitize subjects that might not otherwise respond to PAscH- radio-
chemo-therapy.

Public health relevance
Project Narrative Glioblastoma (GBM) is a highly aggressive, common malignant brain tumor that has a dismal prognosis of only 14 months despite aggressive standard treatment with radiation and temozolomide chemotherapy. Pharmacological ascorbate (IV vitamin C reaching ≈ 20 mM in plasma) is a novel, redox active iron dependent therapy that safely complements and potentially enhances GBM standard therapy. Therefore, due to the iron dependence of ascorbate, supplementation of pharmacological ascorbate with redox active iron (ferumoxytol) may further enhance the observed ascorbate response; this idea will be investigated in a phase 1 clinical trial.